Clinical and Biological Factors Predicting Lung Transplant Textbook Outcomes (U01)

PROJECT SUMMARY/ABSTRACT
While lung transplantation is the only treatment option for end-stage lung disease, early post-operative
complications are common and limit long-term patient survival while concomitantly increasing the economic
burden of an already expensive therapy. Successful surgical outcomes can be defined by an ideal or “textbook
outcome” (TO) where the patient does not have significant early post-operative complications, which for lung
transplant can include primary graft dysfunction, acute lung allograft dysfunction, renal failure or infection. Our group
recently published the first lung transplant TO definition based on single-center data and found failure to achieve TO
was strongly associated with worse patient survival and significantly higher cost to the health system. A subsequent
registry analysis of 62 US lung transplant centers found the rate of achieving TO ranged from 27% to 72%,
emphasizing wide variability in outcomes and potential for intervention and improvement. The Lung Transplant
Clinical Center in this proposal include Duke University, University of Louisville, University of Minnesota and
University of Pennsylvania. These centers are four of the oldest and most respected lung transplant centers in
the country with geographic and size diversity, including small, medium, and large volumes. Our proposal aims
to understand the critical pretransplant clinical characteristics, as well as novel underlying biologic aging differences,
that contribute to worse early outcomes, or failure to achieve a TO. We hypothesize that specific clinical variables and
biological aging measures can predict early complications. Biological age in the pretransplant patient may be driven
by organ specific advanced lung disease and therefore ameliorated with lung transplant. Alternatively, biological age
may be a systemic process across organs systems and does not resolve with transplant. To determine the significance
of organ specific versus systemic aging, we will evaluate pretransplant biological aging in the recipient's pretransplant
immune system and explanted lung. Using iterative machine learning we will develop and validate a TO prediction
model based on the identified clinical variables and biological measurements to determine a personalized
perioperative risk of lung transplantation for individual candidates. More than just a predictive tool, this proposal will
allow for identification of potentially modifiable clinical and biologic variables that can be leveraged to improve
outcomes. As part of the larger Lung Transplant Consortium, we will enroll participants and contribute data and
biospecimens through a common research protocol under the auspices of the Lung Transplant Consortium Data
Coordinating Center and Steering Committee.

Public health relevance
PROJECT NARRATIVE Lung transplant is the only option for treatment of end-stage lung disease, but requires remarkable resources and carries a considerable risk of early post-operative complications. Within our four-transplant center collaboration, we propose a detailed analysis of pretransplant clinical variables and objective measurements of biological aging through mechanistic assays processed with machine learning in order to quantify the risk of perioperative complications and identify modifiable risk factors. Additionally, our centers will help develop and contribute approximately 200+ patients annually (75%+ of annual adult lung transplant volume) to the larger proposed lung transplant consortium.